Psychedelics for Older Adults with Chronic Pain

Summary Abstract
Chronic pain is highly prevalent (38%) condition in older adults and impacts quality of life with increased
depression, anxiety, existential distress, and social isolation, and associated with an increased risk in overall
morbidity and mortality. Existing pharmacologic therapies for older adults have limited efficacy and significant
side effects. Psychedelic Assisted Therapy (PAT) has demonstrated preliminary safety and efficacy for
improving mental health (e.g., depression, existential distress), addiction, and chronic pain in non-elderly
adults. However, published research to date has not included older adults who have been severely under-
represented in studies to date. This lack of safety and efficacy data in older adults is a critical public health
need. To respond to this research gap, we propose the INSPIRE Network (INnovation in Science of
Psychedelics with Inclusive Research in Elders), a geographically diverse, transdisciplinary consortium
comprised of sites with established psychedelic research programs and expertise in geriatrics, chronic pain,
psychiatry, palliative care, and multi-site clinical trials.
Initial research will focus on psilocybin, due to its favorable safety profile and evidence for preliminary efficacy
in related psychiatric conditions (e.g. depression, anxiety, existential distress), and on lysergic acid
diethylamide (LSD), due to early evidence suggesting safety and efficacy in treating pain, as well as psychiatric
and existential distress in advanced cancer pain syndromes. In the UG3 phase, we will evaluate the
pharmacokinetic (PK) and pharmacodynamic (PD) characteristics of these two drugs in healthy older adults,
with results informing selection of drug(s) and doses for the UH3 phase.
In the UH3 phase, we will conduct two randomized trials of PAT in two mechanistically distinct pain conditions:
(i) a predominantly nociplastic condition, chronic back pain, testing psilocybin combined with an emerging
evidence-based therapy for nociplastic pain—Pain Reprocessing Therapy, and (ii) a pain condition with a
substantial nociceptive element, cancer-induced bone pain, testing LSD combined with an existential
psychotherapy. The overarching hypothesis for the UH3 phase studies is that participants randomized to
intervention arm (moderate dose followed by high dose PAT) will have improved pain outcomes compared to
the control arm (placebo followed by moderate dose PAT) at all study time points (4,8,12 weeks) with a primary
outcome of pain interference at 8 weeks. In addition, general measures of mood, sleep, and wellbeing will be
improved in the intervention arm compared to the control arm.

Public health relevance
Chronic pain is a prevalent problem in older adults and causes significant impairment to quality of life. Psychedelics have shown promise in treating a variety of conditions, including improving chronic pain; however, older adults are severely under-represented in studies to date. As psychedelic use has become more widespread, either through underground use or through state-initiated decriminalization and legalization efforts, the lack of safety and efficacy data in older adults is a critical public health need. This research examines the safety of psychedelics in older adults and whether and how these might work to treat chronic pain.